AI-based Mapping of Complex Cannabis Extracts in Pain Pathways

ABSTRACT
There is tremendous interest in cannabis (as smoked marijuana or CBD- or THC-dominant extracts) as a
therapeutic modality for a variety of health indications (including chronic pain). Given the complexity of
cannabis, however, we have little insight into its mechanisms of action in complementary and integrative health
approaches. Specifically, there is a prevailing notion that the 100+ cannabinoids and the various
terpenoids/flavonoids that comprise cannabis act in concert to create an “Entourage Effect”. A comprehensive
analysis is required to better understand the potential of cannabis agents as complementary medicines. We
herein propose a novel artificial intelligence-driven approach to address this gap in our knowledge.
Not surprisingly, a natural product (e.g., cannabis) that is active in an organism typically works because it acts
like endogenous ligands or those known to the organism. We hypothesize that deconstructing ligand
structures into specific fragments will allow us to identify targets that bind endogenous tergets containing such
fragments. Moreover, we believe that disparate compounds acting in concert will maximally engage selective
pathways. We have developed an artificial intelligence (AI)-driven platform, DRIFT (drug-target identification
based on chemical similarity), to map ligand compounds (cannabinoids and terpenoids) to molecular targets.
Thus, we can illuminate involved cellular pathways, and predict physiological response. We will use DRIFT to
profile compounds in a number of different cannabis extracts (e.g., high in CBD, CBG, or THC) with varying
analgesic properties to identify therapeutic combinations and their relevant targets. We will undertake three
specific aims. In Specific Aim 1, use DRIFT for massive mapping of cannabis constituents to corresponding
target proteins. Then, in Specific Aim 2, we will extend the DRIFT platform by evaluating binding affinities
between metabolites and their proteins using a new neural network paradigm (NeuralDock). We will use text
mining techniques to mine compound-protein relationships from PubMed. Finally, in Specific Aim 3, we will
experimentally validate the outputs of the DRIFT platform to predict mechanisms of cannabis on pain. We will
test the AI-based results using traditional pharmacology tools and a variety of preclinical animal models of
pain. These same models will then be employed to test mechanisms through the complementary use of
agonists, antagonists, inhibitors and (where appropriate) gene knockouts to validate mechanisms.
When these studies are successful, we will have validated DRIFT as a new and valuable AI tool for studying
natural products. Moreover, we will provide important insights into the growing use of cannabis in
complementary and integrative health.

Public health relevance
PROJECT NARRATIVE While one of the main therapeutic uses of cannabis is to relieve chronic pain, little is known about the underlying mechanisms. We propose using an innovative artificial intelligence (AI) approach to deconvolute the complex mixture of cannabinoids, terpenoids, and flavonoids that comprise cannabis and its extracts and test these in cell and animal models. When we are successful, we will have provided insight into the use of cannabis in pain and validated this paradigm for understanding a variety of other complementary and integrative (natural products) approaches to health.